Opioid Treatment Adoption in Primary Care Settings: Barriers and Facilitators to Implementation

Project Summary/Abstract
There are almost 3 million Americans with opioid use disorder (OUD), contributing to unprecedented levels of
overdoses and drug-related mortality in the U.S. Several approved medications for OUD (MOUD) are
available, and robust evidence shows them to be more effective than abstinence or psychosocial therapy alone
in helping individuals achieve and maintain remission. Yet, less than 20% of individuals with OUD receive any
MOUD. Buprenorphine maintenance therapy (BMT) holds significant potential to increase access to treatment
as the only MOUD available in a primary care setting that does not require patients to endure withdrawal.
Fewer than 7% of physicians prescribe the drug, and more than 40% of U.S. counties do not have a BMT
provider, with access further restricted in rural and otherwise underserved areas. It seems that provider-,
patient-, and system-level barriers are fueling an “implementation chasm” between the evidence-based
practice for OUD and its actual delivery. The objective of this application for a NIDA Mentored Research
Scientist Development Award (K01) is to support a new assistant professor in the Emory University Rollins
School of Public Health to become a national leader in pioneering innovative, multilevel research on how to
close this implementation chasm and reduce drug-related harms and inequities in those harms. To that end,
this K01 application provides training opportunities in Implementation Science, spatial analysis, qualitative
methods, and addiction medicine. The research aims are designed to reinforce these new skills, using mixed
methods and a conceptual model derived from Implementation Science (i.e., the Consolidated Framework for
Implementation Research and the Diffusion of Innovations theoretical model) to investigate the modifiable
barriers and facilitators to BMT adoption in primary care. Aim 1 uses spatial analysis to develop annual,
county-level measures of OUD and BMT treatment availability and determine the local correlates of unmet
treatment need, both overall and for disparity populations. Aim 2 observes the diffusion of BMT prescribing
among primary care providers, measuring the significant predictors of BMT adoption, including individual-,
practice-, system-, and community-level factors. Aim 3 will identify “positive deviant” counties—i.e., those with
substantial increases in BMT prescribing over time—and conduct in-depth qualitative case studies to
determine the processes associated with successful BMT implementation and sustainment, including novel
models of care and local adaptations of best practices. These studies will provide actionable recommendations
for communities and health systems seeking to increase access to evidence-based care for OUD. The
protected time, resources, and mentorship available through this K01 award will enable Dr. Yarbrough to
emerge as an independent and leading researcher in substance use disorders and Implementation Science
who will help close the implementation chasm for MOUD treatments and improve outcomes for opioid use
disorder patients.

Public health relevance
Project Narrative Despite the ongoing opioid crisis and the availability of effective medications that help individuals with opioid use disorder maintain remission, few health care providers prescribe these treatments, leading to inadequate access to care for patients, especially in rural and other underserved communities. This application will support a new investigator seeking to conduct research that examines the full continuum of dissemination, implementation, and sustainment of substance use disorder treatment, with the goal of identifying effective strategies for aligning the evidence base with actual treatment received by patients. The K01 award will provide mentorship and rich opportunities for developing new research skills and knowledge, enabling the investigator to transition to an independent researcher who will lead national efforts to improve treatment access, reduce drug-related harms, and decrease inequities in access and outcomes.